Preclinical-clinical trials collaboration to effectively advance new combination therapies for atypical neurofibroma in neurofibromatosis type 1

PROJECT SUMMARY/ABSTRACT
Neurofibromatosis type 1 (NF1) is a common cancer predisposition syndrome characterized by the development
of a spectrum of benign and malignant tumors of the peripheral nervous system. Individuals with benign plexiform
neurofibromas (PNF) are at increased risk of developing malignant peripheral nerve sheath tumor (MPNST), a
highly aggressive soft tissue sarcoma that rapidly progresses and is uniformly fatal in patients who present with
unresectable disease. The majority of NF1 MPNST arise from pre-existing neurofibromas, suggesting that these
precursor lesions hold important clues to the developmental origins of MPNST and for identifying novel
therapeutic strategies for MPNST treatment and prevention. Work by our team of intramural and extramural
investigators has demonstrated that malignant transformation of PNF often occurs through the development of
atypical neurofibroma (ANF), characterized by distinct histopathological and molecular features including copy
number loss of the CDKN2A/B tumor suppressor locus. Natural history data shows that these pre-malignant
lesions are direct precursors of MPNST. While clinical trials lead by our group have spurred transformative
advances for the treatment of NF1-associated PNF, including FDA and EMA approval of selumetininb (MEK
inhibitor) for the treatment of pediatric PNF, we have discovered that MEK inhibition does not induce treatment
responses in most ANF and does not appear to prevent MPNST. Surgical resection of ANF has become a
strategy to prevent MPNST. However, surgery may be associated with significant morbidity or infeasible due to
ANF location or presence of multiple ANF. To address the challenges of treating and preventing malignant
transformation of ANF precursor lesions in this vulnerable patient population, we will leverage a robust
infrastructure spanning the preclinical-to-clinical continuum to rapidly test and translate novel therapeutic
strategies to the clinic for the treatment of ANF and to identify response biomarkers. Our work will center on
CDK4/6 inhibition to strategically oppose the dysregulated signaling induced by CDKN2A/B loss. The
overarching goals of this project are to (1) develop single agent and/or combination therapies for ANF informed
by preclinical murine models that spontaneously develop ANF and MPNST, allowing interrogation of therapeutic
interventions at each stage of tumor progression, (2) establish a pipeline to accelerate the translation of first-in-
kind therapies to the clinic to effectively treat ANF and prevent malignant transformation, and (3) identify robust
molecular biomarkers associated with treatment response. Harnessing the specialized expertise of translational
and clinical investigators at the NCI, and extramural experts in NF1 biology and therapeutic development, this
collaborative effort will employ state-of-the-art approaches in preclinical modeling, window of opportunity trials,
single cell analytics, and non-invasive liquid biopsy coupled with integrative multi-omic profiling to understand
ANF to MPNST evolution and drive therapeutic innovation for increasingly aggressive orphan cancers where no
current treatment options exist.

Public health relevance
PROJECT NARRATIVE Neurofibromatosis type 1-associated atypical neurofibromas (ANF) are precursor lesions for a highly aggressive form of soft tissue sarcoma that is uniformly fatal in persons with unresectable disease. Here we propose to develop a robust preclinical-clinical pipeline to accelerate the translation of novel single agent and combination therapies to effectively treat ANF and prevent malignant transformation, while identifying robust biomarkers associated with treatment response. Our integrated and multidisciplinary approach will address the challenges of cancer prevention in an orphan cancer predisposition syndrome and uniquely vulnerable patient population for which no effective medical therapies currently exist.